Role of ATAD3A in Lysosomal Homeostasis and Neurogenesis

PROJECT SUMMARY/ABSTRACT
ATAD3A (ATP family AAA-domain containing protein 3A) is a mitochondrial membrane protein that is implicated
in mitochondrial membrane dynamics. We discovered that dominant mutations in ATAD3A cause a human
neurological syndrome characterized by early-onset peripheral neuropathy, optic atrophy and mild brain
malformation. Patients with loss of function mutations in ATAD3A continue to be identified, presenting with
severe neurodevelopmental defects, supporting the importance of this protein in human health. However, the
root cause of this syndrome at the cellular and molecular levels, as well as strategies to ameliorate the symptoms
remain unsolved issues.
Our long-term goal is to determine the roles of ATAD3A in development and in metabolic homeostasis
as the basis for therapies to treat patients suffering from ATAD3A-associated diseases. The objective of our
proposal is to uncover the mechanisms by which ATAD3A controls nutrition sensing (i.e. mTORC1), lysosomal
biogenesis and neuronal development using Drosophila and ATAD3A patient-derived induced pluripotent stem
cells. Our Central Hypothesis is that ATAD3A plays a key role in mTORC1 signaling and lysosomal biogenesis
through Rag GTPase modulation, and that ATAD3A-dependent nutrition sensing and lysosomal homeostasis
are required for proper neurogenesis and development based on the following compelling evidence. Briefly,
using IP-mass spec and co-IP, we identified endogenous binding partners of ATAD3A, including the lysosomal
proteins RagD, a GTPase required for activating mTORC1, and MiT-TFE proteins, transcriptional factors for
lysosomal biogenesis. We found that ATAD3A forms a complex with active Rag GTPases and MiT-TFE proteins.
This finding helped explain our discovery that Drosophila bearing a dominant negative ATAD3A mutation
(R528W) exhibit defects in nutrition sensing (implicating Rag/mTORC1), and aberrantly elevated lysosomal
content in developing neurons (implicating MITF). In Drosophila, we found that ATAD3A null mutations caused
embryonic lethality with abnormal patterning and morphology of central and peripheral neurons. In addition, we
found that the sizes of brain organoids derived from the patient iPSCs are significantly smaller than those derived
from isogenic controls. We will test our central hypothesis by performing the following Specific Aims: (1) to
determine how ATAD3A regulates mTORC1 signaling; (2) to determine how ATAD3A mutations lead to
abnormal lysosomal biogenesis in neurons; (3) to determine how ATAD3A loss causes neurogenesis defects.
These studies will characterize a novel axis of mitochondria-lysosomal-mTORC1 signaling that should
reveal novel molecular insights into the cellular defects in patient neurons that underlie ATAD3A-associated
neurological diseases. We anticipate the identification of potential therapeutic targets for neurological diseases
associated not only with ATAD3A mutations, but also with defects in mitochondrial and lysosomal homeostasis.

Public health relevance
Project Narrative Mitochondria play a crucial role in metabolism, and lysosomes, another compartment in cells, play a role in cellular waste removal and metabolic homeostasis. We discovered that mutations in a mitochondrial gene that result in human neurological diseases cause not only mitochondrial problems, but also lysosomal dysfunction. Our project will study how mitochondria communicate with lysosomes to achieve balanced metabolism for healthy neurons.